Shared Resource Management

Shared Resources Management Summary
The Shared Resources serve to maximize the quality and innovation of the science conducted by MCC
members by providing stable, reliable, cost-effective access to technologies and services that would be difficult
to achieve otherwise. The University of Minnesota (UMN) Masonic Cancer Center (MCC) currently supports 10
Cancer Center Support Grant (CCSG)-funded Shared Resources, 6 for Basic Sciences (Analytical
Biochemistry, Cancer Genomics, Comparative Pathology, Flow Cytometry, Mouse Genetics, and
Proteogenomics), 1 for Clinical Research (Translational Therapy Shared Resource). and 3 with shared
oversight (Biostatistics, Cancer Informatics, and Genome Engineering). In addition, we are proposing to
develop 2 new Shared Resources: Immunotherapeutics Engineering and Exposures & Effects. The Shared
Resources support all 6 Research Programs and are managed by faculty director(s) with support from
technical expert coordinators. Most Shared Resources are located on the Twin Cities campus and are
strategically positioned to meet the needs of a core group of MCC users. The goal of Shared Resource
Management (SRM) is to provide effective oversight and support to Shared Resources in order to provide our
members with access to technologies and services that enhance the scientific productivity of their cancer-
focused research. The Specific Aims for SRM are to 1) establish, manage, and increase access to MCC- and
UMN-supported Shared Resources that advance the research goals of the MCC membership; 2) establish new
Shared Resources identified as critical to fulfilling the research needs of MCC members; and 3) develop and
implement effective marketing and outreach strategies that increase transdisciplinary, collaborative use of
Shared Resources. The Associate Director of Basic Sciences, Carol A. Lange, PhD (Cellular Mechanisms
Program), and Associate Director of Clinical Research, Melissa Geller, MD (Transplant and Cellular Therapies
Program), oversee SRM and implementation of the scientific vision. Other members of the SRM team include
members of the Shared Resource Internal Advisory Committee, the MCC Finance Director, the Research
Development Manager, and the Shared Resources’ faculty leaders and coordinators. The SRM team is
responsible for determining and evaluating the accessibility and costs of services provided; monitoring quality
and user satisfaction of Shared Resources services through surveys and usage metrics; and ensuring that
Shared Resources evolve in a manner that aligns with MCC strategic priorities. Approximately 75% of all MCC
members utilized one or more of our Shared Resources during the current CCSG cycle. In the coming cycle,
outreach efforts will ensure that the Resources and the services they provide are widely known by MCC
members and the larger UMN community, while still ensuring priority access to MCC members.